An interactive resource to generate and provide integrated knowledge of the human pancreas

PROJECT SUMMARY/ABSTRACT
Type 1 diabetes (T1D) is characterized by autoimmune destruction of insulin-producing beta cells in pancreatic
islets where there is currently no prevention or cure. The processes driving T1D initiation and progression in the
pancreas are poorly understood, and improved understanding of these processes in the pancreas is critical to
gain new insight into disease mechanisms and identify novel biomarkers and therapeutic targets. A wealth of
data has been generated in human pancreas donors in initiatives supported by the Human Islet Research
Network (HIRN) which can be used to address open questions in T1D, yet these data are currently both under-
utilized and in formats inaccessible to many researchers which prohibits insights. To address this gap, we have
assembled a team of highly accomplished researchers to create a pancreatic knowledge base PanKbase
leveraging our expertise in computational biology and data science (Gaulton, Flannick, Voight), type 1 diabetes
(Rich, Atkinson, Anderson, Gauton, MacDonald), islet biology (Gloyn, MacDonald), immunology (Anderson,
Atkinson), knowledge base engineering (Flannick, Gaulton), engagement and outreach (Burtt, Westley), and
rigor and reproducibility (Grethe, Martone). For this proposed project we will in Aim 1 develop a database that
comprehensively aggregates and harmonizes data in HIRN repositories and other repositories containing human
pancreas data based on our existing CMDGA platform. We will further derive high-quality summary resources
from these harmonized data that are of value to the community. In Aim 2 we will implement an analytics library
of tools that address impactful questions in T1D by performing statistical modeling and machine learning of data
and resources, and that extrapolate knowledge learned from these data into large, independent datasets, as
workflows in multiple formats including Github repositories, Jupyter notebooks, WDL pipelines, and pre-
computed results. In Aim 3 we will create an open science platform accessible to any user that provides user-
friendly interfaces to customizable workflows that address impactful questions, an analysis sandbox to run
advanced workflows and pipelines, and APIs and code repositories for full customization, based on the
HuGeAMP and Terra platforms. In Aim 4 we will form collaborations and working groups with investigators
leading HIRN repositories to develop standards and pair experts with data scientists to integrate domain
knowledge into resource creation and machine learning applications using our expertise coordinating consortia.
In Aim 5 we will establish engagement and outreach programs for the broader research community to improve
data, workflows, and user experience in PanKbase and identify new key questions in the field by applying our
extensive expertise in developing outreach for AMP-CMD and the digital platform the (sugar)science. Together
this proposal will provide a knowledge base of the pancreas which will enable researchers across all expertise
levels to extract novel insight and relationships from data in HIRN and other pancreas donor repositories, which
will expedite the development of biomarkers, therapies, and prevention strategies for T1D.

Public health relevance
PROJECT NARRATIVE Type 1 diabetes (T1D) is characterized by beta cell destruction in the pancreas where there currently are no preventions or cures. A wealth of data has been generated on the human pancreas by the Human Islet Research Network (HIRN) and other sources that can be used to understand T1D and identify biomarkers and therapies; however, these data are currently under-utilized by researchers. The proposed project will address this gap by creating a knowledge base ‘PanKBase’ consisting of a database of harmonized data in the pancreas and high- value summary resources created from these data, an analytical library of tools to extract knowledge from data and resources using statistical modeling and machine learning, an open science platform enabling all users to perform analyses and access data, and a robust engagement and outreach program.